Data Science

PIs: Martin Deschênes, Yoav Freund, David Golomb, David Kleinfeld (lead), Fan Wang
!
Core 3. Abstract
Data Science Core
The role of the Data Science Core is to maintain the digital data and to link to it all experimental results and
derived information (meta-data) from all participants. Material for the Trainable Texture-based Digital Atlas is a
major part of this effort. An analysis workflow is maintained that serves to localize histology stacks and map
experimental results to atlas coordinates. The Core also serves to disseminate the raw and meta data and all
associated software from all studies at the time of acceptance of publications.